Informational flow from mechanosensing to signaling for extracellular matrix stiffness sensing

Project Summary
Tissue stiffness changes during development, aging and diseases. Sensing this stiffness by cells determines
differentiation, proliferation, migration, and survival, which are all important for development and tissue
regeneration. Local tissue stiffening is a hallmark of cancer, sensing of which by cancer cells causes further
tumor progression and metastasis. Understanding stiffness sensing mechanism is thus essential for designing
appropriate treatment strategy against developmental disorders and cancer. A prominent sensor for the tissue
stiffness is a molecular complex located between the cell and the environment, referred to as a focal adhesion.
The first step in stiffness sensing involves transmission of increased level of a force across molecules in the focal
adhesion against higher tissue stiffness. From the on-going funding, we discovered that this differential force
transmission is independent of myosin contractility, the main force generator within cytoskeleton, and strongly
depends on actin polymerization assisted by its nucleators by creating a backward flow against the cell
membrane. The remaining question is how this differential force in response to the tissue stiffness can be
translated to different signals that ultimately regulate cells’ developmental functions. The goal of the proposal is
to understand whether a key focal adhesion-based signaling is caused by sensing activity of a key structural
sensor protein and the force running through it. To achieve this goal, we have developed a set of experimental,
microscopic, computational, and statistical frameworks that allow us to draw a conclusion about causality
between the two time-dependent signals at individual focal adhesions captured from a live-cell imaging and
computer vision. Specifically, we focus on focal adhesion kinase (FAK), which is a signaling hub for focal
adhesion-based signaling but not well known for its coupling to the mechanical sensor, talin. Talin can be
stretched under force and expose binding sites for other molecules like a vinculin, another mechanical linker
protein. The overall objective of this renewal proposal is to use these multi-disciplinary pipelines to test a novel
conceptual model of stiffness sensing in which the stiffness-dependent FAK activation is induced by talin’s
mechanical sensing and the differential force in a manner that is dependent on focal adhesions’ dynamic state.
We will determine 1) if FAK recruitment and activation are caused by talin recruitment and mechanosensitivity,
2) if FAK activation is caused by the mechanical force, 3) how FAK activation promotes RhoA signaling for
stiffness sensing. An enhanced mechanistic understanding of these processes would increase our fundamental
knowledge of how cells sense and respond to tissue mechanics. Thus, the proposed studies are relevant to the
NIH's mission, as they will lead to new insights in physiology and pathophysiology including tissue development,
regeneration and cancer progression.

Public health relevance
Project Narrative Sensing of the physical environment by integrin-based adhesions begins with different force magnitude running through mechanosensitive proteins within the adhesions. This proposal proposes to discover how this force and mechanosensor translates to different signaling that affects cell behaviors such as cell proliferation and migration.